Signaling pathways regulating mechanoreflex sensitization in cardiovascular disease

PROJECT SUMMARY
Hallmark features of many forms of cardiovascular disease include exercise intolerance and a high risk of
suffering an adverse ischemic cardiovascular event such as cardiac fibrillation, myocardial infarction, or stroke
during physical exertion. An exaggerated increase in sympathetic nervous system activity during exercise (i.e.,
sympathoexcitation) is a direct contributor to exercise intolerance and the risk of such adverse events. During
exercise, mechanical forces associated with contracting skeletal muscles stimulate small diameter muscle
sensory neurons (group III/IV muscle afferents) which plays an integral role in the activation of a reflex, the
exercise pressor reflex, that contributes to increased sympathetic nervous system activity during exercise. The
goal of this project is to investigate the cellular signaling mechanisms that result in exaggerated mechanically-
activated exercise pressor reflex sympathetic control signals in cardiovascular disease. Specifically, we will use
a rat model of limb ischemia in which a femoral artery is chronically ligated (a model of simulated peripheral
artery disease) and a complementary blend of molecular and whole-animal approaches to investigate the
signaling pathways within muscle sensory neurons that result in a pathophysiological enhancement of
mechanically-activated channel function. The incorporation of multiple experimental techniques including
molecular, electrophysiology, reflex, and conscious exercise experiments will ensure that our findings are robust,
integrative, and translational in nature. In Aim 1, we will investigate the role played by inositol 1,4,5-trisphosphate
(IP3) receptors and altered calcium signaling in group III/IV muscle afferents in the exaggerated mechanical
component of the exercise pressor reflex (i.e., the mechanoreflex) in rats with chronic limb ischemia. In Aim 2,
we will investigate the role played by exchange protein activated by cAMP (EPAC), especially EPAC 1, signaling
in group III/IV muscle afferents in the exaggerated mechanoreflex in rats with chronic limb ischemia. In Aim 3,
we will investigate the role played by protein kinase C (PKC), especially PKCε, signaling in group III/IV muscle
afferents in the exaggerated mechanoreflex in rats with chronic limb ischemia. This project is innovative because
it is the first to systematically investigate the signaling mechanisms that modulate the function of mechanically
activated channels that contribute to sympathoexcitation during exercise in cardiovascular disease. This project
is significant because the experiments may identity three novel targets (IP3 receptors, EPAC1, and PKCε) for
therapies aimed at mitigating sympathoexcitation, exercise intolerance, and/or elevated risk of ischemic events
in cardiovascular disease patients.

Public health relevance
PROJECT NARRATIVE The goal of our project is to understand the mechanisms by which muscle sensory neurons contribute to exaggerated increases in sympathetic nervous system activity and blood pressure during exercise in cardiovascular disease. The experiments are significant because an exaggerated increase in sympathetic nerve activity results in vasoconstriction of the coronary and peripheral vasculature which leads to reduced exercise capacity and inadequate oxygen delivery to the heart and other tissues. Increasing our understanding of the mechanisms that cause the exaggerated increase in sympathetic nerve activity during physical stress may lead to the development of novel treatment options for cardiovascular disease patients.